A Novel TDP-43-Targeting Circular RNA to Treat Amyotrophic Lateral Sclerosis (ALS)

SUMMARY
Amyotrophic lateral sclerosis (ALS) is a fatal neurodegenerative disease characterized by inclusion bodies
containing the TDP-43 protein in the cytoplasm of motor neurons. These inclusion bodies are caused by TDP-
43 aggregation, which is caused by pathways or mutations that cause TDP-43 to localize to the cytoplasm.
TDP-43 is an RNA-binding protein and its ability to bind mRNA is a critical step in the process that ultimately
leads to TDP-43 aggregates. When TDP-43 binds cellular RNAs, it can “phase separate” and become
enriched in stress granules, where TDP-43 slowly forms insoluble aggregates. A widely accepted therapeutic
goal is to prevent TDP-43 from undergoing phase separation into stress granules, since this is a prerequisite
for TDP-43 aggregation. To block TDP-43 phase separation, we are using RNA aptamers that bind TDP-43’s
RNA-binding domain and thus act as a “decoy” to block TDP-43 from binding to cellular mRNA. However,
RNA aptamers are rapidly degraded in the cytosol. Chimerna scientists have developed an innovative
expression system that allows RNA aptamers to rapidly be converted into “circular” RNAs in cells, thus making
them resistant to cellular exonucleases. This dramatically increases RNA aptamer stability, leading to
expression levels that are at least 100 times higher than any previous expression system. Using this system,
we found that circular TDP-43-binding aptamers can block phase separation of TDP-43 using an optogenetic
TDP-43 phase-separation assay. Since the circular RNAs are cytosolic, they selectively block the cytosolic
form of TDP-43 without affecting the normal function of TDP-43 in the nucleus. The critical question is whether
TDP-43-binding aptamers will prevent TDP-43 aggregation, toxicity, and neurodegeneration in disease-
relevant models. To test this, the specific aims of this proposal are: (1) To evolve TDP-43 aptamers for
higher affinity and lowest IC50 for blocking phase separation. We will use directed evolution to evolve
high-affinity TDP-43 aptamers. We will use our optogenetic platform for inducing TDP-43 phase separation in
cells to calculate IC50 values for the top evolved aptamers. These experiments will reveal the aptamers that
have the greatest potential to disrupt TDP-43 phase separation. (2) To test the ability of circular TDP-43
aptamers to block phase separation, aggregation, and toxicity of TDP-43 in human iPS neurons. Here,
we will use iPS-derived ALS motor neurons that exhibit TDP-43 aggregates, markers of aggregate toxicity, and
increased susceptibility to oxidative stress-mediated cell death. We will determine if TDP-43 aptamers can
block these key parameters of TDP-43 aggregate toxicity, thus providing critical data about the validity of our
aptamer approach using disease-relevant model. Overall, these experiments will test a new concept for
blocking TDP-43 aggregation using highly stable circular TDP-43 aptamers, that will be tested using an
optogenetic phase separation assay and ALS iPS-derived motor neurons.

Public health relevance
PROJECT NARRATIVE TDP-43 aggregation is found in nearly all ALS patients' post mortem tissue, suggesting that aggregation prevention is a valid therapeutic strategy, yet no therapeutic has been developed to target cytoplasmic TDP- 43 aggregation without also affecting normal TDP-43 function in the nucleus. Here we describe a new approach to resolve TDP-43 aggregation using an RNA therapeutic that binds cytoplasmic TDP-43 and blocks and prevents TDP-43 from forming aggregates. We will determine the feasibility for preclinical development of this RNA-based inhibitor by testing its ability to block and potentially reverse TDP-43 aggregation and prevention of motor neuron death in induced pluripotent stem cell models with ALS-linked patient mutations.